Pathway Analysis in Tuberculosis

Overall, Abstract
Despite the availability of therapy, Mycobacterium tuberculosis (Mtb) is the major infectious killer of adults.
Finding more effective therapeutic strategies will require a better understanding of the fundamental biology of
bacterial growth, metabolism and interaction with the host. This program proposes to understand key pathways
in Mtb biology using advanced genetic and biochemical methods, with a particular focus on complex
pathways important in adaptation to disease-relevant stressors. “Pathways” is defined broadly, including
biochemical, structural and genetic interactions. In many cases, traditional genetic approaches to discover and
understand these pathways are limited, but many of the most critical aspects of Mtb biology are mediated by
such complex genetic mechanisms. This program will leverage new methodology and resources that the
collaborators have developed in the last few years, to discover the constituents of key pathways, attribute
functions to new pathways, and understand the mechanisms which underlie the ability of bacteria to survive and
grow under a variety of conditions, focusing on those encountered during infection. They will also take advantage
of the close collaborations among the investigators who have worked well together for several years. The work
will be organized into four projects and four cores, but considerable crossover is expected, which will enrich each
component.
Project 1. Metabolic adaptations required for growth and virulence of Mtb at acidic pH.
Project 2. Acquisition, synthesis and importance of biotin in Mtb.
Project 3. Defining the RNA processing and degradation pathways of Mtb.
Project 4. Defining cell division pathways in Mtb.
Core A. Metabolomics and lipidomics.
Core B. Biochemistry and enzymology.
Core C. Bioinformatics and data sharing.
Core D. Administration.
All of this work will be facilitated by a highly collaborative group of investigators, almost all of whom have worked
together for many years on a large variety of projects. Both project and core investigators will serve as full-
fledged intellectual contributors, enabling the team to bring a variety of approaches and thinking to bear on
complex biological systems.

Public health relevance
Project Narrative Tuberculosis is a major global health burden, killing more than 1.5 million people every year, despite the availability of therapy. Finding more effective therapeutic strategies could transform the epidemic, but that will require a better understanding of the fundamental biology of bacterial growth, metabolism and interaction with the host of the causative agent – Mycobacterium tuberculosis (Mtb). This proposal aims to make advances toward this goal, utilizing innovative techniques to understand therapeutically relevant pathways in Mtb.